Implicating the major G-quadruplex helicase, DHX36, as a novel pathogenic modifier of C9ORF72 frontal temporal dementia

This proposal uses innovative approaches to uncover underlying molecular mechanisms and develop a novel
treatment strategy for frontal temporal dementia (FTD), the second most common form of young-onset dementia
and an Alzheimer-disease related dementia. Unfortunately, there are no treatment options that prevent or slow
FTD. A mutation in C9ORF72 (C9) is the most common cause of FTD and amyotrophic lateral sclerosis (ALS),
collectively referred to as C9 ALS/FTD. This mutation leads to an abnormal excess of DNA and RNA structures,
termed G-quadruplexes. Increased G-quadruplex burden contributes to accumulation of toxic RNAs and proteins
leading to neuron degeneration and disease onset. As such, C9 ALS/FTD is fundamentally a ‘G-quadruplex
disease’. Within the cell reside helicase enzymes that unwind G-quadruplexes. DHX36 is a major G-quadruplex
helicase, accounting for the majority of G-quadruplex helicase activity in human cells. In the previous funding
period, it was shown that DHX36 enhances production of toxic C9 proteins via repeat-associated non-AUG
(RAN) translation. It was also shown that RAN translation of toxic C9 proteins during cellular stress requires
DHX36, linking DHX36, stress, and RAN translation for the first time. DHX36 localizes to stress granules
following stress, however it is unknown if the presence of DHX36 in stress granules is directly connected to
DHX36 effects on C9 RAN translation. For Aim 1, it is hypothesized that loss of DHX36 reduces C9 protein
translation through reduction of stress granule abundance. This hypothesis will be tested using C9 patient-
derived cells, mouse primary brain neurons, and in vivo transgenic mouse models. In addition to a cytoplasmic
effect of DHX36 on RAN translation, preliminary data suggest that DHX36 may protect C9 ALS/FTD cells from
increased DNA damage in the nucleus. These observations suggest that nuclear DHX36 may be protective while
cytoplasmic DHX36 may exacerbate C9 ALS/FTD. For Aim 2, it is hypothesized that specifically targeting
cytoplasmic DHX36 is a viable therapeutic strategy that reduces toxic C9 protein production while preserving
protective effects of nuclear DHX36. This hypothesis will be tested using human C9 ALS/FTD patient-derived
neuronal progenitor cells. This research builds on a long-standing collaboration between three research groups
led by Dr. Philip Smaldino (Ball State U.), Dr. Yuh-Hwa Wang (U. of Virginia), and Dr. Peter Todd (U. of Michigan),
with additional support from Dr. Lindsey Hayes (Johns Hopkins U.) and Dr. Ashley Kalinski (Ball State U.). The
proposed studies will be the first to determine the role of DHX36 in stress responses and genomic integrity in C9
ALS/FTD and is poised to identify DHX36 as a novel therapeutic target. Undergraduate and graduate students
will be integrated at every stage of the project allowing them to gain authentic experience with innovative cell
and mouse technologies applied to a deadly human disease. Completion of this work will include the training of
~24 research lab students and over 150 students in Course Undergraduate Research Experiences (CURE)
taught by the PI, giving this proposal high potential to inspire future dementia-disease researchers.

Public health relevance
This project will study frontal temporal dementia (FTD), a devastating neurodegenerative disease without a cure, commonly caused by a mutation in C9ORF72, which causes the production of toxic RNA and proteins leading to neuronal death. This research will determine the roles of a major G-quadruplex helicase, DHX36, in stress responses and genomic integrity in C9 FTD (and related C9 ALS disease), and will also initiate the development of a novel therapeutic strategy targeting DHX36 in C9 ALS/FTD, while integrating dozens of students into cutting edge, biomedically-relevant research.